Culture–specific neurodevelopmental assessment of HIV-affected children

With NIH funding we have developed BPG (Brain Powered Games), a CCRT (Computerized Cognitive
Rehabilitation Therapy) digital games package for HIV+ school children in the sub-Sahara. As a child plays,
BPG will gather game data for neurocognitive assessment. BPG has been pilot-tested in HIV+ children.
In Study Aim 1 we will evaluate concurrent and predictive validity. Here we will evaluate whether BPG static
(baseline) assessment will correspond well to our gold standard static measures (KABC-II, TOVA, CogState).
Compared to these, we hypothesize that dynamic BPG assessments will provide for a more sensitive
evaluation of brain/behavior function as affected by more proximal factors of HIV exposure, disease and
treatment. We also hypothesize that dynamic assessments will be more sensitive to distal developmental risk
factors (e.g., SES, nutrition/growth, maternal caregiving quality).
In Study Aim 2 we will compare the validity of BPG static and dynamic assessments. Here we will validate
BPG static and dynamic assessments with a gold standard of neuropsychological tests previously used with
children 5 -12 years old at our two study sites (Kampala, Uganda and Blantyre, Malawi). Children will be in 3
cohorts: 1) HIV-positive; 2) HIV exposed and uninfected (HEU); 3) HIV unexposed and uninfected (HUU).
Cohorts will be well characterized due to participating in our previous NIH-sponsored HIV clinical trials. We
hypothesize that BGP-based static and dynamic assessments will be sensitive to cohorts’ prior longitudinal
trajectories as affected by proximal and distal risk factors that cause developmental delay and cognitive
problems, as measured in our previous clinical trial studies with these cohorts.
In Study Aim 3 we will test the sensitivity of dynamic assessment to learning loss after training ends. An
advantage of dynamic assessment should be its sensitivity to learning loss over time as a measure of strength
of positive neuroplasticity in brain/behavior functions. Here we will test sensitivity by evaluating all 3 cohorts
with BPG and gold standard tests (KABC-II, TOVA, CogState) 6 months after the children complete their 12
sessions of BPG training. We hypothesize that BPG dynamic assessment of learning loss at 6-month follow-
up post-CCRT will be especially sensitive to integrity of brain/behavior function in pediatric HIV.
Overall Impact: BPG will be the first CCRT validated for dual cognitive assessment, both static and dynamic.
We expect BPG’s dynamic assessment capability will provide fundamental new insights into how HIV disease
and treatment affects brain development, enabling sensitive and accessible cognitive measurement tools for
clinical trials. BPG can also be an accessible and inexpensive assessment tool in resource-constrained
settings to enable community health workers to monitor brain development in children burdened by other
diseases and injuries. It can do so as a mobile-based tablet or smart phone device lending itself to easy
scalability of language-free cognitive testing, which can be done as part of cognitive rehabilitation intervention.

Public health relevance
BPG (Brain Powered Games) is designed as a CCRT (Computerized Cognitive Rehabilitation Therapy) for HIV-positive school-age children living in Sub-Sahara Africa; used to train a child’s fine motor skills, monitoring/attention, visual/auditory working memory, and spatial navigation ability. We will test whether BPG games cognitive assessment data gathered as HIV-affected children play with BPG can be analyzed to better understand how HIV risk factors affects a child’s developing brain. While children undergo CCRT intervention, we expect to demonstrate that we can analyze game data on a child’s performance dynamically across playing sessions, which will be an advance over the common practice of analyzing data from just one cognitive testing session.